The role of mitochondrial DNA mutations in chemotherapy induced cardiomyopathy

The role of mitochondrial DNA mutations in chemotherapy induced cardiomyopathy.
Doxorubicin(DOX), a broadly applied cancer therapeutic, is a significant contributor to irreversible
cardiomyopathy. Evidence suggests that DOX treatment-induced cardiomyopathy is associated with elevated
levels of mitochondrial DNA (mtDNA) mutations. Mitochondria (mt) are critical for cardiac myocyte physiology,
and it is not surprising, therefore, that mtDNA mutations effect cardiac myocyte function and are associated with
cardiomyopathy. However, it is unclear if or how the mtDNA mutation load contributes to cardiomyopathy. This
question is confounded by the fact that disease presentation can be dependent on the heterogeneity of
“diseased” vs “healthy” mitochondria in a given cell or cell population, known as mitochondrial heteroplasmy.
Here, I will use patient genetics and iPSC-derived cardiomyocytes to resolve how mtDNA gene variants or
mutations affect DOX-induced cardiomyopathy. The overarching goal of this proposal is to resolve whether
specific mtDNA mutations and/or the proportion of mutated vs non-mutated mtDNA should be treated as a risk
factor or interpreted as causative in the development of cardiomyopathy after DOX treatment.
I hypothesize that mtDNA mutations are induced or selected for in patients treated for cancer and that mtDNA
mutations and that their heteroplasmic load plays a causative role in the cardiomyopathy developed after cancer
treatments such as DOX. We will test this hypothesis through patient-based association studies: 1) mining the
100,000 Genomes Project database to identify risk factors between cancer treatments, the development of
cardiomyopathy, and the presence/heteroplasmic load of specific mtDNA mutations. In addition, I will perform
functional studies using phenotypic and genetic high throughput screening approaches in iPSC-derived
cardiomyocytes to determine 2) whether DOX induces de novo versus selects for pre-existing mtDNA mutations,
and 3) whether induced or selected mt mutations directly cause myopathy.
The results of this investigation should resolve whether DOX causes mutations or selects for pre-existing
variants, and should help inform clinical decision making by answering the key question of “Should patients that
are heteroplasmic for certain mtDNA variants be monitored carefully after DOX treatment?” Moreover, it should
lay the groundwork for my future research career, in which I would like to develop therapeutic strategies to
potentially alter mtDNA heteroplasmy in patients at risk for developing cardiomyopathy after cancer treatment.
Thus, it is important to identify the selection events in a patient’s life that could contribute to creating or increasing
the presence of mtDNA mutations, especially since there are no current treatments for mt disease.

Public health relevance
Project Narrative Cardiomyopathy as a consequence of cancer therapeutics such as Doxorubicin is a major problem, and evidence suggests that mitochondrial dysfunction, whether pre-existing or stimulated by treatment, correlates with Doxorubicin-induced cardiac dysfunction. The goal of this project is to understand how mitochondrial DNA mutations influence whether or not a patient develops cardiomyopathy after his/her cancer treatment. The results of this study may lend to clinical decision making for chemotherapeutic selection and cardiac monitoring in patients carrying certain mitochondrial DNA mutations.